Mechanistic Investigation of Copper-Dependent Peptide Cyclases for Macrocycle Engineering

PROJECT SUMMARY
Macrocyclic peptides are effective scaffolds for antibiotic drug discovery as they can combine the oral
bioavailability and cell membrane permeability of small molecule drugs with metabolic stability and target
specificity of biologics. The 14-membered bicyclic darobactin is a peptide antibiotic lead structure against Gram-
negative multi-drug resistant bacteria. Darobactin is defined by two side-chain-to-side-chain-macrocyclic bonds,
cyclized by a radical S-adenosylmethionine (SAM) iron-sulfur cluster enzyme. Due to synthetic challenges
towards darobactin macrocyclic complexity and the anaerobic nature of its radical SAM cyclase, a biocatalytic
alternative is needed to produce and diversify 14-membered bicyclic peptides in an aerobic environment. BURP
domain proteins have recently been characterized from plant genomes as copper-dependent autocatalytic
peptide cyclases, which catalyze the formation of darobactin-type macrocycles under aerobic conditions.
BURP domain proteins constitute precursor peptides of plant ribosomally-encoded and post-translationally
modified peptides (RiPPs). BURP domain precursor peptides include core peptide motifs and a C-terminal BURP
domain, which catalyzes the cyclization of amino acid side chains in the core peptide in a copper-dependent
reaction. BURP domain-derived peptides have diverse macrocycles: mono- and bicyclic scaffolds, 14- to 21-
membered rings, and C-O, C-N- and C-C-macrocyclic bonds. Despite the chemical diversity of their cyclopeptide
products, the structure and mechanism of BURP domain cyclases are completely unknown. Based on
preliminary work, I hypothesize that BURP domain cyclases use a redox active copper cofactor, a radical-based
mechanism, and require dioxygen for catalysis. Electron paramagnetic resonance will identify the presence of
radical species and Cu(I) in BURP domain catalysis, and anaerobic reconstitution of recombinant BURP domain
cyclases followed by bottom-up proteomic analysis will characterize dioxygen as a cofactor. In this proposal, the
protein structures of two representative BURP domains will be determined in Specific Aim 1. Type I BURP
domain cyclases encode a single core peptide within the BURP domain, represented by the bicyclase from
peanut, AhyBURP. Type II BURP domain cyclases have a repetitive N-terminal core peptide domain attached
to the BURP domain, and will be investigated from African clubmoss, the peptide bicyclase SkrBURP. Specific
Aim 2 uses AhyBURP and SkrBURP to elucidate the catalytic mechanism of BURP domains. I also predict that
BURP domain cyclases can be engineered to yield tailored macrocycles. Specific Aim 3 is to generate mimics
of the antibiotic darobactin by rational design of SkrBURP, and testing the efficacy of these darobactin mimics
against drug-resistant pathogenic bacteria. The proposed research of BURP domain cyclase engineering
represents the possibility to generate new macrocyclic peptide libraries to address antimicrobial resistance.

Public health relevance
PROJECT NARRATIVE The World Health Organization designated antimicrobial resistance as one of the top ten global public health threats in 2020; the production and diversification of new antibiotics are urgently needed. Peptide natural products with aryl-based macrocyclizations, such as vancomycin and darobactin, are an important source of antibiotics, but their synthetic production has been challenging due to the target macrocycle chemistry. Plant- derived BURP domain cyclases are a new class of copper-dependent enzymes that aerobically cyclize aryl- based peptides and will therefore be investigated to rationally engineer mimics of darobactin for screening against multi-drug resistant pathogenic bacteria.